Mechanisms of Carcinoma Differentiation and Invasion

DESCRIPTION (provided by applicant): The overarching question to be addressed in this proposal is how loss of estrogen receptor β (ERβ) function in tumor cells contributes to prostate cancer. The expression of ERβ is diminished in prostate cancer, especially in aggressive, high Gleason grade tumors and its loss contributes to a de-differentiated, EMT phenotype. Importantly, loss of ERβ increases expression of Bmi-1, a Polycomb group transcriptional repressor that functions as an oncoprotein and has been implicated in the self-renewal of prostate tumor stem cells. A key issue that arises from these findings is how loss of ERβ contributes to Bmi-1 expression and the putative regulation of tumor initiating cells. ERβ stabilizes HIF-1α?and promotes HIF-1-mediated transcription but the mechanism involved in this critical process has not been resolved. This mechanism is extremely important and relevant because high-grade tumors exhibit significantly elevated expression of HIF-1α?but clinically relevant hypoxia is not seen in localized primary prostate cancer including high-grade tumors. These observations indicate that loss of ERβ in prostate cancer mimics hypoxia by stabilizing HIF-1α. It is proposed that ERβ is necessary for the expression of specific prolyl hydroxylases that target HIF-1α?for degradation, providing a potential mechanism for how loss of ERβ induces HIF-1α, and that a major consequence of this mechanism is enhanced VEGF transcription and VEGF-mediated induction of Bmi-1. Collectively, this application will address the novel and exciting hypothesis that ERβ impedes the acquisition of an EMT process that expands the population of tumor initiating cells and enhances their self-renewal, and that the progression of prostate cancer can be diminished by sustaining ERβ function. To validate this hypothesis, two specific aims are proposed. The first aim will determine that ligand-dependent activation of ERβ promotes the proteosomal degradation of HIF-1α?by sustaining the transcription of prolyl hydroxylase 2 (PHD2), and that loss of ERβ expression or function diminishes PHD2 expression resulting in HIF-1α?stabilization and HIF-1 activation that promotes a de-differentiated, EMT phenotype. The second aim will establish that ERβ signaling suppresses the HIF-1-mediated transcription of VEGF, which functions in an autocrine manner to sustain the expression of Bmi-1, promote an EMT and contribute to the function of prostate tumor initiating cells. Thus, it will be determined that loss of ERβ and PHD2 contribute to tumorigenesis and aggressive disease by promoting an EMT and increasing the frequency of tumor initiating cells.

Public health relevance
This proposal seeks to understand why some prostate carcinomas are much more aggressive and offer a worse prognosis than others. The major goal of this proposal is to understand how loss of a specific form of the estrogen receptor causes prostate tumors to be more aggressive. To accomplish this goal, we will establish inhibits the genesis of cells that are capable of initiating tumors and making tumors more aggressive.